Early life stress and differential effects on the molecular maturation of specific subtypes of brain serotonin neurons

Project Summary/Abstract
Extreme adversity and stress in early life, affecting over one in three children, can perturb critical processes in
brain development that may increase risk for mental illness throughout life. Possible underlying neurobiological
pathways and temporal windows of particular sensitivity are explored in this R21 study in which we focus on a
newly discovered organizational structure and maturation trajectory for the many different subtypes of brain
serotonin (5-HT)-producing neurons across early postnatal life in mice. Rodent studies show neurobiological
modifications in response to early life stress (ELS) that include brain 5-HTergic neurons, and clinical studies
implicate diminished 5-HT-mediated neurotransmission. Thus, the ‘ground state’ of brain 5-HTergic neurons
may change with ELS, and by adulthood, the causal pathway may no longer be present. Little is known about
which of the many brain 5-HTergic neuron subtypes are vulnerable, what molecular mechanisms and timing
underlie the ELS-sensitivity, and how this relates to long-term brain and behavioral dysfunction. This is now
discoverable, through precision brain cell access tools in mice, advances in single-cell (sc) ‘omics,’ and recent
discoveries – many from our group – that rewrite the organizational map for the brain 5-HTergic neuronal
system. We now know that the adult brain 5-HTergic system in mice is organized into over twenty neuronal
subtypes that, while sharing generic 5-HTergic features, are otherwise distinct molecularly, and in many cases
also shown to be distinct functionally and hodologically. Mapping the embryonic 5-HTergic neuronal system
has revealed fewer subgroups. Lacking have been studies across postnatal development at a resolution
sufficient to identify 5-HTergic neuron subtypes and reveal potential molecular pathways and temporal
sequences by which the mature subtype organization arises. We recently generated transcriptomic (scRNA-
sequencing) data across postnatal development and discovered several novel features distinguishing the
various 5-HTergic neuron subtypes that may be impacted by ELS. These findings provide a high-resolution
developmental map of the emergence of brain 5-HTergic neuron subtypes and their differential windows of
maximal maturational change as reflected in the state of their transcriptome and epigenome. Here we apply
this new 5-HTergic system ‘lens’ to reveal short- and long-term cellular, molecular, and epigenetic effects of
two well-documented early life [day 2(neonatal) through 15 (childhood)] exposures in mice: transient daily
maternal separation (Aim 1), and chronic daily administration of a selective serotonin reuptake inhibitor (SSRI),
fluoxetine (Aim 2). Discoveries will include neurobiological pathways sensitive to early life exposures and which
may have relevance to human psychopathologies that originate early in life.

Public health relevance
Project Narrative Adversity and stress early in life can perturb critical processes in brain development that can increase the risk for mental illness throughout the lifespan. Possible underlying brain mechanisms are explored in this study in which we focus on a newly discovered organizational structure and maturation trajectory of different subtypes of serotonin-producing neurons in the brain across early life in mice. Expected research outcomes of significance to public health include discovery of molecular and cellular pathways that might offer therapeutic leads in the prevention and better treatment of psychiatric disorders that have their origin in childhood.